PHYSIOLOGY &BIOPHYSICS 201 OPTICAL BIOLOGY

Introduction to research in optical biology techniques developed in the LAMMP facility. Students concentrate on learning basics of instrumentation, data analysis, and unique applications to biological systems. 1-4 units per quarter.